INITIAL THERAPY OF WILSON'S DISEASE WITH AMMONIUM TETRATHIOMOLYBDATE

The purpose of this study is to evaluate the efficacy and toxicity of ammonium tetrathiomolybdate in the initial therapy of Wilson's disease patients presenting with neurological disease.